Administrative Supplement to Molecular Segregation of Parkinson’s Disease by Patient-derived Neurons

Summary
Dementia is an age-dependent co-morbidity of Parkinson’s disease (PD) that affects up
to 80% of PD patients. There is very little mechanistic understanding of PD Dementia (PDD),
which together with Dementia with Lewy Body (DLB), constitute Lewy Body Dementia (LBD).
The lack of a suitable model system significantly hampers the study of this complex disorder,
which shares many features with Alzheimer’s disease (AD). In our preliminary study, we
developed a method to differentiate induced pluripotent stem cells (iPSCs) to cortical neurons.
Comparing cortical neurons derived from normal subjects and sporadic Alzheimer’s disease
patients, we found significant increases in TAU phosphorylation and significant decreases in the
expression of synaptic genes. In our parental R01 grant, we have developed a method to
differentiate iPSCs to A9 dopaminergic (DA) neurons. In midbrain DA neurons derived from
normal subjects and idiopathic PD patients, we have found significant differences in the
expression of genes handling dopamine. Premised on these findings, we hypothesize that
iPSC-derived cortical neurons and A9 dopaminergic neurons from LBD patients may exhibit
molecular and cellular features that are significantly different from those of normal subjects.
Three specific aims will be addressed to test the hypothesis, which extends the parental R01
grant to dementia in this administrative supplement application. We will generate cortical
neurons (Aim 1) and A9 DA neurons (Aim 2) from iPSCs of LBD patients and normal subjects to
examine the phosphorylation and aggregation states of TAU and -synuclein, and compare the
global gene expression profile. We will confirm key findings in postmortem tissues from middle
temporal cortex and substantia nigra of LBD patients and normal subjects (Aim 3). Information
generated in this focused study will lay the foundation for discovery of LBD biomarkers using
patient-derived neurons. Key targets identified in the study can be validated in drug discovery
efforts to address cognitive, memory and motor symptoms of LBD using patient-derived cortical
neurons or A9 DA neurons. The administrative supplement application will move the field
forward by identifying molecular and cellular features that distinguish LBD from normal subjects
in patient-derived neurons and postmortem tissues.

Public health relevance
Project Narrative This Administrative Supplement application will identify molecular and cellular features of Lewy Body Disorder (LBD) in cortical neurons and A9 dopaminergic neurons differentiated from induced pluripotent stem cells of normal subjects and LBD patients. The results will be validated in human postmortem brain tissues.